Control of Circuit Hyperexcitability by Endogenous Opioids in Epilepsy

Epilepsy is a devastating neurologic condition that affects about 2 million Americans and is often resistant
to medical treatment. Animal studies have demonstrated that epilepsy is associated with compensatory
changes in the brain, which includes the aberrant rewiring of neuronal circuits. In particular, epilepsy is
associated with altered connectivity in the hippocampus, a region of the brain that is frequently the focal point
for the initiation of seizures. One particular hippocampal circuit rearrangement associated with epilepsy
involves the growth (“sprouting”) of hippocampal granule cell axons (the mossy fibers) in a retrograde direction.
These sprouted fibers could directly cause hippocampal hyperexcitability by forming recurrent excitatory
circuits, or alternatively increase the activity of inhibitory mechanisms and prevent seizures.
Using a combination of novel approaches, our recent work determined that these fibers directly drive
retrograde excitation and hyperexcitable circuit function. Interestingly, a large proportion of these retrograde
projections derive from newly generated, adult-born granule cell neurons, which are produced in large numbers
after seizures and undergo aberrant maturation and circuit integration. This suggests that these adult-born
neurons might contribute substantially to seizure initiation and propagation, if they alter the balance of
excitation and inhibition in the hippocampus.
At the same time, sprouted mossy fibers have long been known to produce multiple peptide
neurotransmitters, which include endogenous opioid peptides. Although the receptors for these peptides are
known to potently control neuronal excitability throughout the brain, the functional importance of endogenous
peptides in the control of hyperexcitability in epilepsy has not been explored. Notably, even basic questions
regarding the conditions under which these peptides are released, the functions of specific receptors in
different cell types, and whether these peptides modulate seizure frequency or severity in epilepsy are not
known. Thus, their role during epileptogenesis remains a long-standing unanswered question in the field, and
represents a therapeutic opportunity.
With this proposal, we will answer fundamental questions regarding the roles of these peptides in the
control of hippocampal function in epilepsy, and how potential alterations in opioid peptide signaling
mechanisms due to enhanced neurogenesis might overwhelm endogenous control mechanisms that prevent
seizures. We have combined various lines of genetically modified mice, which allow us to specifically label and
optogenetically control different subsets of hippocampal granule cells in live tissue. We will induce
experimental epilepsy using the well-established pilocarpine model of epilepsy, and use electrophysiologic
recording techniques to study the functional roles of these peptides in the hippocampal circuit. Furthermore, we
will use additional genetic manipulations to modify the electrical activity of peptide-releasing cells in epileptic
mice in vivo, to determine how this affects seizures.
Our work will provide insights into the function of opioid signaling in epilepsy, and allow us to determine
whether sprouting from various cohorts of granule cells differentially modulates hippocampal excitability. This
will answer long-standing questions regarding the pathogenesis of acquired epilepsy, by directly defining the
functional role of the sprouted mossy fiber pathway and its various peptide signaling mechanisms. An
understanding of the mechanisms through which opioids control hippocampal excitability could lead to a novel
therapeutic approach to potentially prevent seizures after neuronal injury.

Public health relevance
Veterans recovering from neuronal injury frequently develop epilepsy, and acquired epilepsy accounts for up to 50% of symptomatic epilepsy nationwide. Mechanisms underlying the development of epilepsy after neurologic insults are unclear, but human and animal studies suggest that it involves the rewiring of neuronal circuits in the hippocampal region of the brain. These changes include the addition of new neurons with altered functional and structural properties, and the growth of opioid peptide-containing fibers. Through our functional analysis of these aberrant connections in live tissue, we have determined that although newly born neurons contribute to circuit hyperexcitability, endogenous opioid systems may counteract this excitation and help prevent seizures. This proposal aims to understand how these two systems interact, with the goal of identifying endogenous mechanisms that prevent seizures. Through this work, we hope to eventually design therapies to prevent and treat acquired epilepsy, including epilepsy that develops after TBI, stroke or infection.